Preconceptional health of Latinas and its association with child adiposity

Abstract:
Hispanic children have a higher prevalence of overweight/obesity than their non-Hispanic
counterparts. Perinatal maternal health status and lifestyle behaviors are recognized as
important risk factors for childhood obesity. Pre-pregnancy maternal obesity is linked to higher
infant birth weight and increased risk of offspring obesity. The maternal diet and metabolic
profile during preconception has been shown to adversely affect the subsequent health of the
offspring, including the development of obesity. However, the data are scarce for Hispanics
from various backgrounds and limited, in general, due to the lack of standardized
documentation of preconception health. The Hispanic Community Health Study/Study of
Latinos (HCHS/SOL), a cohort of 16,415 adults (including 3,801 women 18-44y) from four U.S.
cities, is the largest health study of Hispanics/Latinos in the US. Baseline data, including
cardiometabolic markers and diet, were collected from 2008 to 2011, and reproductive history is
being collected at visit 2 from October 2014 to 2017. Hence, HCHS/SOL offers a unique
opportunity to prospectively investigate the role of preconceptional maternal health status
(cardiometabolic biomarkers and diet) on the development of childhood obesity and to
understand drivers of overeating, such as food reward-related behaviors and psychological
stress of women as predictors of child feeding practices and weight. This ancillary study
proposes to recruit 440 mother-child dyads; these are women of reproductive age with a child
(ages 3-7y) born since the baseline examination to assess child's weight, height and adiposity
(total fat mass as measured by DEXA), eating and other lifestyle behaviors, and women's food
reward-related behaviors. We propose to identify early modifiable determinants of child's weight
and adiposity status that are not attributable to the genetic environment. This is a novel use of
an existing cohort to answer very timely and important research questions that have the ability
to contribute to the development of intervention studies during this very critical time period in the
lifecycle of both the mother and child for the Hispanic population.

Public health relevance
Narrative: The proposed project will measure the association among maternal preconception cardio- metabolic markers and diet, and child weight and adiposity (total fat mass using DEXA) in a well-characterized Hispanic/Latino population in the United States. This study will improve our understanding of the association between maternal preconception health and childhood obesity – a topic that is not well studied yet is important given the poor cardiovascular health status and high prevalence of childhood obesity among Hispanics/Latinos. The results from this study will be used to design better intervention studies to ensure the optimal health of Hispanic/Latina women before conception as well as the health and wellbeing of their offspring.